Cloud based neuroimaging analysis for identifying traumatic braininjuries and related changes

Project Summary (30 lines max)
This proposal outlines plans to evaluate the performance and utility of cloud-based data processing for
computationally demanding analysis of MRI-based brain imaging data. This administrative supplement would
build on the aims of a recently awarded R01 which develops classification algorithms for identifying and tracking
progressive pathology associated with mild traumatic brain injury (mTBI) in a population of high-risk individuals.
Over the last decade, our team has been continuously funded by NIH to collect detailed clinical and neuroimaging
protocols from over 4000 high-risk men and women. Our extant data include multimodal neuroimaging protocols
(sMRI, fMRI, DTI), thorough clinical assessments, neuropsychological evaluations, and histories of TBI. The
aims of the current project are to generalize existing classification algorithms for mTBI from community samples
to high-risk forensic samples and to improve on an objective neuroimaging-based measure of cognitive decline.
On traditional platforms, these neuroimaging-based classification tools involve hundreds of thousands of
potential features and require running times of several weeks, even for relatively small numbers of subjects.
Given the computational complexity of the analyses required for this project, cloud-based computing platforms
could be highly advantageous in terms of efficiency. We propose, first, to containerize our customized
neuroimaging pipelines for pre-processing, followed by implementation of our current locally implemented
classification algorithms. A cloud-based solution will allow us to explore several algorithmic approaches towards
feature selection and union in a shorter time frame than using a local server-based solution. In order to test the
feasibility and advantages of cloud-based processing, we will build data processing pipelines and validate them
using existing data. Specifically, we would like to prototype algorithmic approaches towards detecting trait related
changes in neural connectivity and test these using extant data collected under NIH support and from publicly
available neuroimaging databases (e.g. FITBIR). Indeed, one of the aims of our R01 award is to test the
generalizability of our algorithms to data in FITBIR (readily available). This testing could begin as soon as
supplement was received. The cloud-based platform versus local-server-based processing will be evaluated in
terms of data processing speed and costs (including human working hours). These objective measures will give
us a clear picture of the value of implementing cloud-based processing on a larger scale, including applications
for the longitudinal aims of the current grant.

Public health relevance
Here we propose to develop cloud-based solutions to process high volume brain imaging classification algorithms for traumatic brain injury.